Minnesota Postbaccalaureate Research Education Program in Diabetes, Endocrinology and Metabolic Diseases

MN PRIDE is a unique postbaccalaureate program for diverse college graduates, offering a two-year intensive
research experience combined with advanced graduate courses. Leveraging UMN's extensive research
expertise in Diabetes, Endocrinology, and Metabolism (DEM), MN PRIDE aims to shape the future generation
of researchers in DEM-related research. The program fills a crucial gap in UMN's doctoral readiness program,
specifically tailored for a diverse workforce in DEM-related research. MN PRIDE is closely linked with
established T32 training programs in DEM, Obesity, and Inflammation, and provides access to resources from
the Minnesota Institute of Diabetes, Obesity, and Metabolism. Participants will be paired with two of the 29
experienced faculty mentors, known for their DEM-related research leadership and commitment to mentoring
diverse trainees. This sets the stage for independent research projects, academic growth, and publication
opportunities. To achieve MN PRIDE's goal of preparing participants for doctoral programs with a focus on
diabetes research, MN PRIDE doctoral readiness program will employ a multifaceted approach: 1. Providing
trainees with exceptional research experiences to develop laboratory competence and multidisciplinary
research skills regarding DEM. 2. Offering high-quality mentorship, including senior/associate mentors (mentor
dyads) to support trainee and associate mentor development. 3. Assuring a path to graduate program entrance
with application process guidance and guaranteed interviews. 4. Facilitating skill development, such as
manuscript writing and effective communication in science, while also helping trainees navigate the
complexities of graduate school. Financial provisions are in place to ensure a smooth transition to graduate
programs. These include three additional postbaccalaureate positions in Year 2 for peer-to-peer engagement,
relocation expenses, application fee waivers, and other program-related expenses. In conclusion, MN PRIDE
is a comprehensive program aimed at creating the next generation of DEM researchers, equipping
postbaccalaureate trainees with the necessary skills, knowledge, and support to receive further graduate
training (PhD, MD/PhD) to address significant health challenges posed by DEM-related disorders.`

Public health relevance
The Minnesota Postbaccalaureate Research Education Programs in Diabetes, Endocrinology, and Metabolic Diseases Program (MN-PRIDE) fills a crucial gap at the University of Minnesota (UMN) by training the next generation of diverse researchers dedicated to addressing diabetes and its associated health issues. This endeavor is made possible through the collaboration of experienced faculty members known for their excellent mentoring and cutting-edge core facilities, creating an exceptional training program for our participants. The goal of the MN- PRIDE program is to help participants build a robust research portfolio, which will facilitate their smooth transition into research-focused doctoral degree (PhD, MD/PhD) programs, thus supporting their success in conducting research related to diabetes, endocrinology, and metabolic diseases.